Leadership, Planning and Evaluation

Abstract: Leadership, Planning and Evaluation
Leadership, Planning and Evaluation UPMC Hillman Cancer Center’s (HCC) planning and evaluation activities are well-developed and provide invaluable guidance to the HCC Senior Leadership Team (SLT): Interim Director (Kathryn Schmitz, PhD, MPH), Interim Deputy Director (Jose Zevallos, MD, MPH), Associate Director for Research Administration (Theresa Cummings, DBA, RN) and the Associate Directors for Basic Research, Clinical Research, Population Sciences, Training and Education, Shared Resources, and Community Outreach & Engagement. Individually accomplished, with strong scientific and leadership achievements, they work collectively as the SLT HCC’s primary decision- making body for setting the Center’s overall strategic direction. The SLT provides direction in issues relevant to HCC operations, management, and policy, and oversees all research activities. This leadership team also sets budgetary and fiscal priorities and reviews HCC membership. In addition to the SLT, several key internal and external governance structures provide the primary means by which the HCC conducts ongoing planning and evaluation: the Research Executive Advisory Committee (REAC), Shared Resources Oversight Committee (SROC), Clinical Research Oversight Committee (CROC), Committee for Community Outreach & Engagement (CCOE), Committee for Excellence in Cancer Education and Training (CECET), and the Internal and External Advisory Boards. The REAC includes the SLT, Program and Shared Resources leadership, and key senior HCC members, and is an effective mechanism for information exchange among HCC stakeholders. The External Advisory Board (EAB), comprising recognized leaders in basic, clinical, translational and population sciences, and cancer center administration, meets at least annually to review all aspects of HCC operations and new initiatives. Additional planning input is provided by retreats, other Center advisory committees, surveys and ad hoc external reviews. With careful planning and critical input from the different advisory groups, HCC leadership initiated an important strategic visioning and planning process, reorganized the research program structure, and created new committees to continuously improve oversight and governance. These coordinated teams provide critical advice and guidance, ensuring that the HCC effectively sets priorities and pursues objectives that promote its mission.